A Hydrogen Sulfide Delivery Technology for Organ Preservation Therapy

Project Summary/Abstract
Nearly 1 in 3 people with diabetes and 1 in 5 people with high blood pressure suffer from chronic kidney disease (CKD),
while approximately 2 in 1,000 Americans are living with end-stage kidney disease (ESKD)—kidney failure that is treated
with a kidney transplant or dialysis. Despite the high cost of transplantation, there are nearly 100,000 patients waiting for
transplantable kidneys each year in the US and only 1:6 patients receive a transplant. The shortage in viable donor kidneys
results in significant mortality in the ESKD patient population. Ischemia-reperfusion injury (IRI) is a barrier to successful
transplant surgery and an underlying cause of post-surgical delayed graft function (DGF), acute kidney injury (AKI), graft
rejection, chronic rejection, and chronic graft dysfunction. It can lead to an overwhelming economic burden due to higher
length of hospitalization and the eventual need for a more costly option, dialysis. IRI follows a sustained period of
ischemic/hypoxic condition and occurs as a consequence of kidney vasculature blood supply restoration, sudden tissue
re-oxygenation, and production of toxic substances including reactive oxygen species (ROS) that give rise to oxidative
stress, cell death, and tissue damage. There has been significant progress in organ preservation methods to reduce IRI and
improve delayed graft function, among which hypothermic machine perfusion (HMP) has been shown to stand out as the
method of choice. Recent studies reveal that perfusate solutions supplemented with hydrogen sulfide (H2S) can provide
additional cryoprotective benefits and extend the viability of kidneys while improving post-transplantation functional
recovery. H2S, a gasotransmitter primarily produced in the vascular endothelial cells, plays an important role in
vasorelaxation, angiogenesis, and cytoprotection while it downregulates inflammation, apoptosis, and tissue necrosis. In
kidneys, endogenous H2S regulates renal blood flow, glomerular filtration rate, diuresis, natriuresis kaliuresis, blood
pressure, oxygen sensing, medullary blood flow, and renin-angiotensin-aldosterone system (RAAS). Preclinical and clinical
evidence link low H2S bioavailability to endothelial dysfunction and ischemic-reperfusion injury in kidney transplants. In-
vitro and in-vivo studies indicate that supplementing the preservation solution with an H2S donor such as AP39, GYY4137,
and NaHS increases epithelial cell viability, improves mitochondrial potency, reduces acute necrosis, and significantly
improves ischemia–reperfusion injury. To-date, widespread clinical translation of H2S therapy is hindered by significant
concern over safe use and unintended off-target effects of most H2S donors due to a lack of control and knowledge over
the dosage during treatment. This leaves a significant opportunity for a disruptive approach for targeted, precision delivery
of H2S to facilitate clinical translation of H2S therapy. The proposed Phase I STTR study aims to demonstrate the benefits
of a unique electrolytic technology, Genie:S™, for precision delivery of H2S to the perfusate in an HMP kidney preservation
system. This collaboration between Exhalix, University of New Mexico School of Medicine, and Texas A&M School of
Veterinary Medicine, combines in-depth expertise in device engineering, vascular physiology and surgery, transplant
surgery, and animal studies for successfully achieving the proposed aims, and is expected to advance to Phase II effort and
beyond for the development of investigational devices for evaluation in preclinical and clinical studies.

Public health relevance
Project Narrative Ischemia-reperfusion injury (IRI), prevalent in the majority of organ transplantation cases, is particularly prominent in inhibiting post operative kidney transplantation functional recovery. One in five deceased donor kidneys are discarded to avoid complications due to IRI, unacceptable delayed graft function (DGF), and high risk of morbidity. This proposal addresses the need for a transformative kidney preservation technology that promises to accelerate clinical translation of hydrogen sulfide therapy, scientifically proven to improve the viability of organs during cold preservation and better outcome in renal transplantation surgery.